Neurophysiology of Reward Signaling in Parkinson's Disease

PROJECT SUMMARY
Altered reward signaling plays a key role in multiple Parkinson’s disease nonmotor symptoms including
depression, apathy, and impulsive and compulsive behaviors. Moreover, therapies for Parkinson’s disease
including dopaminergic medication and deep brain stimulation have been associated with both pathologic
increases and decreases in reward guided behaviors. Unfortunately, symptoms of altered reward signaling
such as depression, apathy, and impulsive and compulsive behaviors lack effective therapies. A better
understanding of the neural signaling underlying reward signaling is crucial to developing better treatments for
these disorders. This proposal for a mentored clinician scientist research career development award for Dr.
Sarah Bick capitalizes on access to human intracranial recordings in neurosurgical procedures to characterize
reward signaling neurophysiology in the subthalamic nucleus and dorsolateral prefrontal cortex. Dr. Bick has
previously demonstrated that subthalamic nucleus and dorsolateral prefrontal cortex beta power increase
during reward and that dorsolateral prefrontal cortex reward related power is associated with depression and
apathy. The specific aims of the present study are to 1) characterize neurophysiology correlates of reward
signaling in subthalamic nucleus and its connectivity with dorsolateral prefrontal cortex, 2) determine how
acute subthalamic nucleus stimulation perturbs reward signaling, and 3) determine how chronic STN
stimulation alters reward signaling.
Dr. Bick’s long-term goal is to develop improved neuromodulation strategies for cognitive and
psychiatric disorders such as Parkinson’s disease nonmotor symptoms. To accomplish this, her objectives
during the period of this award are: 1) to develop expertise in advanced computational techniques such as
machine learning to apply to neurophysiology analysis, 2) to gain experience with neurophysiology connectivity
analysis, and 3) to learn analysis methods for MRI structural connectivity. VUMC is the ideal environment to
foster her development into an independent investigator studying the neurophysiology of cognitive and
psychiatric processes in order to develop novel neuromodulation techniques. The environment includes a
strong team of NIH funded mentors and advisors with expertise in neurophysiology, advanced computational
techniques, structural connectivity, engineering, and Parkinson’s disease, a high clinical volume of the patient
population needed to recruit study subjects, and strong institutional resources to support career development
of physician scientists. The project will thus provide a platform for Dr. Bick to establish preliminary data and
critical research skills to launch an independent research career.

Public health relevance
PROJECT NARRATIVE Reward processing is critical to our ability to make everyday decisions, and deficits in reward signaling can lead to symptoms such as depression, apathy, and impulsive and compulsive behaviors. Patients with Parkinson’s disease have decreased dopamine leading to altered reward signaling. In this study we will use intracranial recordings and stimulation to probe neural signaling underlying altered reward signaling in patients with Parkinson’s disease and how it contributes to specific nonmotor symptoms.